Healthy Adolescent and Young Adult Self-Management in Spina Bifida

Project Summary/Abstract
Spina bifida (SB) is the most common congenital chronic health condition involving the central nervous
system. Self-management (SM) of this chronic health condition requires a complex daily regimen to address a
wide range of physical disabilities, orthopedic conditions, and neurogenic bowel and bladder. Successful SM is
critical because this population is at high risk for early mortality from co-morbidities. Improving the health and
quality of life (QOL) of individuals and their families living with this condition depends on advanced self-
management behaviors, skills, and abilities for better outcomes across the lifespan. The proposed K01
Mentored Research Scientist Development Award will facilitate Dr. Monique Ridosh in establishing an
independent research career. Dr. Ridosh will gain expertise in statistical methods for longitudinal analysis,
strengthen knowledge in quantitative methods, increase knowledge of family measurement through multi-
method (observational, questionnaire, and interview) and multi-respondent (family members, teachers,
healthcare providers) data sources, and gain knowledge and experience in data science for future spina-bifida
related translational and clinical research. Research training will provide an opportunity to examine
longitudinal data to understand predictors of self-management in individuals with a complex chronic health
condition, specifically spina bifida. This training will be provided in a strong institutional environment at
Loyola University Chicago and supported by expert interprofessional scientists from nursing, psychology,
public health sciences, and medicine.
The objective of this application is to identify factors that predict trajectories of self-management
among adolescents and young adults with SB. This proposal will provide evidence that (1) characterizes the
trajectory of self-management, (2) identifies factors related to self-management, and (3) explains how family
factors (family functioning, stress, and perceived family support) moderate the relationship between predictors
of self-management and outcomes (self-management, health status, and QOL). These data will inform
development of interventions for this population of individuals with SB and their families.
Aligned with NINR’s scientific focus on self-management to improve health and QOL, this study will
analyze existing data for predictors of SM in adolescents and young adults over time. Since risk factors for
adverse SB outcomes (bowel and bladder incontinence, mobility difficulties, presence of pressure sores) vary by
age, gender, and race, differences in trajectories as a function of demographic factors will be determined.
Moreover, the proposed analyses will identify salient modifiable factors that may be important components of
family-focused self-management interventions to improve health and QOL and reduce mortality associated
with health complications.

Public health relevance
Self-management strategies are necessary to address the secondary conditions of spina bifida, a congenital chronic health condition, for better health and well-being of adolescents and young adults. Adults with spina bifida are at increased risk for early mortality due to health complications, which may be preventable when youth engage in successful self-management and achieve independence. This study will characterize the trajectories of self-management and identify predictors of successful self-management, better health status, and quality of life in youth with spina bifida to facilitate the development of precision health strategies that engage youth and their families in preventive health behaviors.